Device-free, long-term monitoring of opioid circuit activity in individual mice exposed to fentanyl

Abstract
While the incidence of Opioid Use Disorder (OUD) continues at epidemic levels, a necessary step in the
development of improved OUD therapeutics is to understand the adapting molecular architecture and functional
dynamics neural circuits responding to opioids. Despite extensive research to date, it remains unclear how
opioidergic circuits in various brain regions modulate neural activities and opioid gene expression patterns across
stages of the addiction cycle (e.g., drug naïve, acute exposure, chronic exposure, and abstinence) within the
same animals. To better capture the molecular and activity underpinnings of OUD, our collaborative team of
bioengineers and circuit physiologists will develop a new approach for long-term monitoring of opioid-induced
changes in neural population activity and opioid receptor gene expression with a simple blood test, called
Released Markers of Activity—RMAs—that translocate from neurons into the peripheral blood stream. Thus, the
breakthrough potential of RMAs for OUD discoveries are illustrated by their device-free and within-subjects
measurement features with around-the-clock, weeks-long monitoring, as well as modular use for both neural
activity and genetic alterations as provided by our novel viral promoters that give genetic access to active
populations and opioid receptor-expressing cell-types. In Aim 1, we will clone our 2nd generation “erasable”
RMAs (eRMAs; protease cleavable variants for higher signal-to-noise detection amplification across time) under
an activity-dependent viral promoter system to measure increased and/or decrease neural activity in two key
brain regions for OUD—before, during and after abstinence from morphine and fentanyl exposure, within the
same animal. In Aim 2, we will clone eRMAs under a new opioid receptor promoter system that would permit a
new class of long-term gene expression measurement related to the up- or down-regulation of the mu-opioid
receptor following chronic morphine and fentanyl exposure. Across both aims we will target this new blood-based
monitoring system to key brain regions implicated in OUD: ventral tegmental area, nucleus accumbens, and
central amygdala. The RMAs for OUD approach will enable us to understand how opioid exposure influences
neural population functions and opioid receptor expression that are related to OUD-related behavior in mice.
Beyond our lab, this innovative and team-driven project will result in the creation of an easy-to-implement and
fast, device-free blood monitoring system for researchers to accelerate the pace of research in opioid addiction
and future development of new OUD treatments. In principle, RMAs for OUD are not limited to mice but any
genetically intractable model system, such as rats, human iPSC brain organoids, pigs, and non-human primates,
which we will explore after successful completion of the CEBRA R21 goal: To develop Release Markers of
Activity for detecting neural activities and opioid gene expression across the OUD cycle in individual mice.

Public health relevance
Narrative Improved technologies for preclinical measurements of opioid-induced changes in brain activities and associated gene expression patterns may accelerate the pace of fundamental discoveries for the translational development of opioid use disorder therapies. Here, our team will develop a new device-free approach for long-term, repeatable monitoring of morphine-induced in neural ensemble activities and opioid receptor gene expression with a simple blood test, called erasable Released Markers of Activity—eRMAs.